IGNITE KUH Professional Development Core

PROFESSIONAL DEVELOPMENT CORE ABSTRACT
The University of Virginia (UVA), Virginia Commonwealth University (VCU) and Virginia Tech (VT), each have
well developed Professional Development programs for pre- and post-doctoral trainees participating in basic or
translational biomedical research. However, educational opportunities in KUH generally are sparse. This
proposal addresses this deficiency. We plan to take advantage of the particular strengths of each institution and
the revolution in web-based conferencing in response to the pandemic to help create an effective multi-
institutional training program. The majority of classes and seminars offered to our trainees will be both in person
and on-line, so that the institutional strengths can be shared by all. Hence, the inclusion of three primary
institutions as well as other participants serves as a strength, rather than a weakness of the training program.
An advantage of the heavy emphasis on web-based conferencing is that it will familiarize trainees with the
technologies that are the wave of the future in science and medicine. Another point of emphasis in our
professional development plan is intellectual property education. Aim 1: To teach trainees skills that enable
them to tackle all aspects of career development. These include effective written and oral presentations;
enhancing overall communication skills; and developing an effective professional network. Trainees will be
immersed in a team science approach to aid in networking and exposure to cutting-edge technologies including
on-line communication. Aim 2: To provide trainees with mentoring skills and to improve the mentoring
skills of preceptors. Mentoring will include formal didactic training and informal basic and clinical research
training. The program will avail preceptors with teaching forums and trainee evaluations in order to improve
mentoring.